Research Education Core

RESEARCH EDUCATION SUMMARY
As the population of older adults increases dramatically, age-related illnesses such as Alzheimer’s disease and
related dementias (ADRD) present a great public health burden. Comprehensive training is required to effectively
and efficiently develop future leaders poised to make the next breakthroughs in ADRD. The Columbia University
(CU) ADRC Research Education Component (REC) is uniquely positioned to provide this training. In its inaugural
cycle, the REC has identified, supported and trained 16 early career investigators drawn from clinical, basic,
translational and epidemiologic fields, as well as fields beyond traditional pathways to ADRD, with promise for
becoming leaders in the field of ADRD research. These REC scholars have engaged in a range of distinct and
complementary training activities including a monthly REC seminar covering core scientific topics in ADRD, and
a monthly joint seminar with RCMAR to provide specific training in the study of at-risk ADRD populations.
Additionally, REC scholars participated in a broad range of didactic opportunities including clinical shadowing,
professional development sessions, grant writing workshops, scientific talks, and dissemination of research
findings to the community via the ADRC newsletter. Ten of the sixteen scholars were awarded funding to carry
out multi-year, mentored pilot research. REC scholars have made progress toward a variety of metrics, with six
securing grant funding, seven with NIH grants under review, four preparing NIH grants for submission, and four
receiving promotions. Scholars actively publish in peer-reviewed journals, collectively producing 33 papers
during their REC tenure with an additional twelve under review. In the next cycle of the grant, the REC proposes
to both continue and enhance the established training program, by providing didactics to a larger community of
earlier career investigators, collaborating with the ORE Core to provide REC scholars with skills in inclusive
research practices, synergizing with the wider community of training programs to strengthen the ADRD training
pipeline, and creating opportunities for REC scholars to develop mentorship skills. Together, the aims of the
REC directly support the goals of the CU ADRC by providing comprehensive training to the next generation of
ADRD scientists with emphasis on the center’s themes including emerging pathways-pathologies relationships
in ADRD, the way in which such relationships are influenced by the lived experience of older adults, and best
practices for investigating at-risk ADRD populations.